ANTIVIRAL TARGET FOR KAPOSIS ASSOCIATED HERPESVIRUS

This application is to examine molecular targets of herpesviruses so that antivirals and vaccines can be developed for prevention and treatment of viral diseases. In this application, we intend to use standard molecular biology techniques to define viral targets and set up assays that can be applied to future drug search. Commercial application is not provided here. PROPOSED COMMERCIAL APPLICATION: NOT PROVIDED